Epidemiologic Study of Hepatocellular Carcinoma in the US

DESCRIPTION (provided by applicant): Hepatocellular carcinoma (HCC) is one of the most fatal malignancies in the world. Five-year survival rate of the disease is only 10%. The incidence of HCC has been steadily rising in the US. SEER data show that the rate more than doubled during the past 30 years. Although HCC is still rare in the US, the rapid increase in incidence has raised concerns on possible changes in underlying risk of the disease. Emerging evidence suggests that the biologic consequences of energy imbalance resulting from a lifestyle of high-calorie diets and physical inactivity may play a role in the etiology of HCC. This possible link of lifestyle to HCC has significant implications in public health because the increasing prevalence of overweight and obesity in our societies indicates that the incidence of HCC may continue to rise accordingly. Evidence also indicates significant host susceptibility to HCC reflected by low penetrance single nucleotide polymorphisms involved in regulation of cell proliferation, apoptosis, immune response to viral infection, inflammation, and other cancer-related cellular activities. To confirm if energy imbalance is independently involved in the etiology of HCC and to identify what genetic susceptible factors are associated with HCC risk, we propose an epidemiologic study of HCC in the states of Connecticut and New Jersey. The study will examine all known and suspected risk factors of HCC among Americans and evaluate the possible link of HCC to lifestyle factors related to energy balance. The investigation will also assess genetic polymorphisms in a genome- wide scope to determine host susceptibility to HCC. Synergistic interplay between energy imbalance and hepatitis virus infection will be another focus of this investigation. A population- based case-control study is designed to investigate these issues. The study will enroll 1,250 incident HCC cases through rapid case ascertainment. Two thousand and five hundred population controls with frequency match to cases on age, gender, race and state will also be recruited. The control subjects will be selected randomly from the state residents through random digital dialing. Questionnaire information and biologic specimens will be collected to assess the exposure of known and suspected risk factors of HCC and to examine possible genetic susceptibility and host- environment interaction. The study will generate valuable information on HCC in the US and may identify risk factors responsible for rising HCC in the US.

Public health relevance
PUBLIC HEALTH RELEVANCE: The research proposal is developed to investigate the etiology of hepatocellular carcinoma (HCC) among Americans and to identify the reasons responsible for the continuing rise of HCC incidence over the past 30 years in the US. The study will enroll 1,250 incident HCC cases in the states of Connecticut and New Jersey and 2,500 population controls with frequency match to age, gender, race and residence regions. Known and suspected risk factors of HCC will be investigated, including lifestyle factors, hepatitis virus infection, diet, medical history, family history of cancer, and single nucleotide polymorphisms which will be evaluated through genome-wide scan in 1,000 cases and 2,000 controls and additional validation in another 800 cases and 1,100 controls. The research proposal is developed to investigate the etiology of hepatocellular carcinoma (HCC) among Americans and to identify the reasons responsible for the continuing rise of HCC incidence over the past 30 years in the US. The study will enroll 1,250 incident HCC cases in the states of Connecticut and New Jersey and 2,500 population controls with frequency match to age, gender, race and residence regions. Known and suspected risk factors of HCC will be investigated, including lifestyle factors, hepatitis virus infection, diet, medical history, family history of cancer, and single nucleotide polymorphisms which will be evaluated through genome-wide scan in 1,000 cases and 2,000 controls and additional validation in another 800 cases and 1,100 controls. __SpecificAimsTextDelimiter__ A. Specific Aims Hepatocellular carcinoma (HCC) is one of the most deadly cancers. The five-year survival rate of the disease is only 10%. The incidence of HCC has been steadily rising in the US. SEER data show that the rate has more than doubled during the past 30 years. Reasons for the increase remain elusive. Given the dismal survival outcome of the disease, rising HCC incidence has raised concerns about its potential impact on public health. Although HCC is still relatively uncommon in the US, the steady increase in incidence indicates possible changes in underlying risk of the disease. Emerging evidence suggests that the biologic consequences of energy imbalance resulting from a lifestyle of high calorie diets and physical inactivity may play a role in the development of HCC. This possible link of lifestyle to HCC has significant implications in public health because the increasing prevalence of overweight and obesity in our society indicates that the incidence of HCC may continue to rise following the trend of lifestyle. The effect of energy imbalance on HCC may substantially differ by the status of hepatitis virus infection. Energy imbalance and hepatitis virus infection may also have strong synergistic interplay in HCC. Evidence further suggests significant host susceptibility to HCC implicated by a wide range of genetic polymorphisms which may act favorably or unfavorably with environmental and lifestyle risk factors in facilitating the development of HCC. To confirm if energy imbalance is involved in the etiology of HCC, to understand what risk factors are responsible for the continuous increase of HCC in the US, and to examine which genetic factors are involved in host susceptibility to HCC, we propose a large population-based case-control study of HCC among Americans in the US. The study will determine not only the relationship of HCC to lifestyle factors that affect energy balance and interact with other HCC risk factors, but also assess the genetic polymorphisms that may underlie host susceptibility to HCC and possible gene-environment interaction. The specific aims of the study include. Aim 1: To investigate the risk factors of HCC among Americans with focus on lifestyle factors and energy balance. Specifically, we will examine the associations of HCC with body mass index, weight gain, total energy intake, physical activity, energy balance, dietary habit, alcohol intake, and type 2 diabetes among study subjects. These analyses will be compared before and after adjusting for hepatitis virus infection to assess the impact of viral infection on lifestyle factors. The analyses will also be repeated among subjects stratified by their status of hepatitis virus infection to determine if the associations differ by the status. Aim 2: To identify single nucleotide polymorphisms (SNPs) and haplotypes that are associated with HCC risk through a genome-wide search. Specifically, we will use the Illumina human660w-quad BeadChip to scan 550,000 SNPs for their associations with HCC. Different genetic models, dominant and multiplicative, will be employed to assess the association of HCC with genetic factors, and the analyses will be adjusted for major risk factors and confounding variables, including demographic features, hepatitis virus infection, and lifestyle factors. SNPs with high minor allele frequency and strong association with HCC will be selected for validation. Aim 3: To assess if genetic susceptibility differs by hepatitis virus infection or lifestyle factors, and to explore if there are interplays or effect modifications between genetic factors and viral infection or lifestyle factors. Specifically, we will analyze the associations of HCC with genetic factors in subjects stratified by their status of hepatitis virus infection, demographic features, and lifestyle factors to compare their differences and similarities. We will also examine the statistical interaction between genetic factors and viral infection, demographic features or lifestyle factors, and perform subgroup analysis to determine their synergies in association with HCC.